The Effects of Visit Characteristics on Patient-Clinician Interactions and Health Outcomes in Knee Osteoarthritis

Project Summary/Abstract
Non-specific/non-pharmacologic therapeutic effects can improve health outcomes, however, little is known
about how to maximize these effects, particularly for effects related to patient-clinician interactions. These
effects are especially important in treating chronic pain. Preliminary studies indicate that both increased visit
length and augmented visit content (designed to elicit a holistic understanding of the individual) enhance non-
specific effects related to patient-clinician interactions, but it is unclear which of these factors is more important
or if their interaction is synergistic. This proposal’s long-term goal is to advance the science of non-specific
therapeutic effects related to patient-clinician interactions to improve health outcomes. Its objective is to
quantify the relative effects of, and mechanisms by which, increased visit length and augmented visit content
affect patient-clinician interactions and health outcomes in knee osteoarthritis (OA). Knee OA is an ideal
condition for studying the effects of visit length and content on patient-clinician interactions and health
outcomes because it is a leading cause of chronic pain and disability in older adults, many common treatments
have poor safety profiles, and clinical trials of medications for knee OA suggest that non-specific therapeutic
effects account for a major component of treatment effects. The central hypothesis is that both increased visit
length and augmented visit content will increase the non-specific treatment effects associated with diclofenac
gel (a standard topical treatment for knee OA-related pain). Project specific aims are: 1) To determine whether
increased visit length and/or augmented visit content increase the non-specific treatment effects of diclofenac
gel on knee OA pain and function; 2) To determine how visit length and content affect patient and clinician
behaviors and physiology during patient-clinician interactions; and 3) To determine whether patient COMT
genotype modifies the effects of increased visit length and augmented visit content on knee pain. The approach
is innovative in that there are few randomized trials targeting non-specific effects associated with patient-
clinician interactions, and none that directly test the effects of visit length and content on health outcomes or use
physiologic measures to assess patient-clinician interactions. The proposed study is significant because it will
determine the relative contributions of visit length and content on health outcomes in knee OA and advance
understanding of potential clinical, behavioral, physiologic, and genetic mechanisms through which non-
specific effects impact health outcomes. This project advances a line of research focused on improving
outcomes in knee OA by developing and testing strategies to modify clinical care delivery to maximize non-
specific therapeutic effects associated with patient-clinician interactions. It will also help develop new research
approaches for studying patient-clinician interactions. Insights gained from this project will also be relevant to
other chronic and painful conditions, may help reduce polypharmacy among older adults, and will advance
understanding of the roles of non-specific therapeutic effects in health outcomes.

Public health relevance
Project Narrative The proposed research is relevant to public health as knee osteoarthritis is a leading cause of chronic pain and disability in older adults, and strategies are needed to reduce pain and improve physical function for individuals with this condition. The proposed research is relevant to the mission of NIA in that it focuses on a common health condition in the aging population and seeks to understand the clinical, behavioral, physiologic, and genetic mechanisms by which non-specific therapeutic effects impact health outcomes in this population. This line of research will improve outcomes in knee OA, and eventually other chronic and painful conditions, by developing and testing strategies to modify clinical care delivery to maximize non-specific effects associated with patient-clinician interactions and enhancing efforts to understand the role of non-specific effects in health outcomes.